Deriving a de novo adolescent addiction treatment from developmental brain data

PROJECT SUMMARY
Dr. Feldstein Ewing is applying for a Mid-Career Investigator Award (K24) to support her development of
innovative, translational (clinical + imaging) research in adolescent alcohol treatment. The K24 would protect
time to facilitate her mentorship of emerging investigators. Her career development and training aims are
tightly and synergistically linked to advance planned research aims. Dr. Feldstein Ewing's 5-10 year research
plan is to develop more efficacious treatment for adolescents who struggle with addiction. Dr. Feldstein Ewing
believes that advances from this area are most likely to stem from integrative approaches that directly query
the developing brain, and aims to tailor articulated interventions that are responsive to that very specific period
of neural development. Translational research in adolescent addiction is very labor intensive. K24 research
funding is requisite to provide Dr. Feldstein Ewing with protected time from the call of clinical and
administrative duties, which in this type of hospital/medical care setting are often highly time intensive, but
unfortunately do not advance research, training, or mentorship. Thus, protected time available within this
mechanism would facilitate precisely the type of protected coverage requisite for freeing up the investigator to
learn more about existing interventions in the field of adolescent psychopathology, adolescent learning and
memory, and advanced quantitative methods that can be used to maximize existing data that the candidate
already has, to propel the field forward in terms of developing novel interventions for high-need adolescents
struggling with addiction. This protection would also facilitate protected time for Dr. Feldstein Ewing to engage
and involve mentees at every stage of this process. As with many other academic medical training centers,
without this K24, this type of protected research/training time will not otherwise be available to Dr. Feldstein
Ewing. This coverage is crucial for advancing innovations in adolescent treatment, at a critical juncture where
the resources and opportunity are available for this work to be done. This is a high area of interest and need
for NIAAA; this K24 award would launch a new field of scientists to start true progress in this domain of
adolescent alcohol and addiction research, and its intervention.

Public health relevance
PROJECT NARRATIVE Dr. Feldstein Ewing has a strong track record of grantsmanship within NIAAA. This Mid-Career Investigator Award (K24) proposal would offer the requisite protected time to support Dr. Feldstein Ewing's exploration into under-investigated aspects of adolescent treatment response in the field of alcohol addiction, along with needed protected coverage to mentor the next generation of patient-oriented treatment researchers in this important arena.